EFFECT OF UREMIA AND ACIDOSIS ON INSULIN INDUCED PROTEIN ANABOLISM

The goal of the study is to quantitate the effect of insulin on protein degradation, amino acid oxidation and protein synthesis rate in patients with chronic renal failure.